Characterizing estrogen regulation of neuronal excitability in the extended amygdala

Project Summary/ Abstract
Alcohol use disorder poses a monumental public health challenge in society, but the mechanisms behind
this disease are not fully understood. Estrogen (17β-estradiol, E2) is a steroid hormone that coordinates sex
differences in brain architecture, neuronal circuitry, and behavior and has been implicated in addiction and other
psychological disorders. E2 can regulate behavioral function by to binding estrogen receptors (ERs) in the brain
and initiating genomic and/or rapid signaling mechanisms. Our lab has shown that female rodents in a high
ovarian E2-state (proestrus) consume more alcohol compared to males and when they are in a low E2-state
(metestrus). In addition, we have found that mice in proestrus exhibit decreased avoidance than those metestrus
and males. In vivo infusion of ERα-specific E2 into the bed nucleus of the stria terminalis (BNST) of metestrus
mice increases drinking levels to proestrus levels but does not change avoidance behaviors. These data suggest
that E2 signaling in the BNST modulates neuronal activity in different ways during binge drinking compared to
during anxiety. We have also demonstrated that corticotropin-releasing factor (CRF) neurons from the BNST
(BNSTCRF) are critical for modulating anxiety behaviors and alcohol consumption, and robustly express ERs.
Initial ex vivo electrophysiology experiments indicate that BNSTCRF neurons are a heterogeneous population,
and persistently firing neurons have a more excitable phenotype present in proestrus animals compared to those
in metestrus. We have also found evidence that their passive and kinetic properties exhibit E2-state dependent
changes that may be contributing to higher excitability. We hypothesize that persistent firing BNSTCRF neuron
excitability is being mediated through different E2 signaling mechanisms, and this is contributing to our observed
behavioral effects. In Aim 1, I will use electrophysiology to parse out whether these neurons’ excitability
properties are stimulated in response to rapid E2 and if there is ER-specificity in these effects. I will also test
whether EtOH alters the excitability of these neurons, and if so, whether E2 status or sex plays a role in the
sensitivity. In Aim 2, I will use snRNAseq to probe whether genes are differentially regulated depending on E2-
state or sex, which would indicate a genomic mechanism at play. If the genes for voltage-gated ion channel
genes that control excitability are differentially regulated, the effects on their corresponding currents will be
queried through electrophysiology. In doing these experiments, diverse mechanisms of E2 signaling present in
BNSTCRF neurons will be revealed.

Public health relevance
Project Narrative Alcohol use disorder presents a significant level of comorbidity with mental health conditions such as anxiety disorder, particularly among women. We find that high levels of estrogen during the estrous cycle correlate with an increase in alcohol drinking, lower levels of anxiety, as well as increased activity in BNSTCRF neurons, a population we have shown to mediate these behaviors. Investigating the link between these behaviors and estrogenic signaling in these neurons will facilitate the development of more targeted treatments for alcohol use and anxiety disorders.